Improving age-related risk assessment and documentation for diverse older adults with cancer

PROJECT SUMMARY
Melody K Schiaffino, PhD, MPH is a tenure-track Assistant Professor at San Diego State University (SDSU), a
core faculty member in the Center for Health Equity, Education, and Research in Radiation Medicine and
Translational Science at UC San Diego, and Associate Member of the UCSD Moores Cancer Center. Dr.
Schiaffino received her PhD in Health Services Research in 2014 and MPH in Epidemiology in 2008. As a
health disparities systems scientist, Dr. Schiaffino’s goals are to identify organizational and provider-level risk
factors that affect how care is delivered to diverse older adults undergoing treatment for cancer to improve sub-
optimal care delivery and treatment outcomes. Older, specifically minority, adults are at greater risk due to the
higher symptom burden and treatment-related toxicity risk of cancer therapy. The proposal entitled, Improving
age-related risk assessment and documentation in diverse older adults diagnosed with cancer, seeks to
examine provider and documentation barriers that result in sub-optimal assessment of age-related risk. Age-
related risk assessments are a series of evidence based clinical tests and screening that can improve cancer
treatment planning for older adults, it is especially salient for older adults experiencing language barriers.
There is currently insufficient research on the mechanisms contributing to sub-optimal assessment and
documentation of age-related risk in radiation oncology. While evidence supports improved communication and
cancer outcomes for patients when age-related risk is assessed, recent clinical trial findings show that only 1 in
4 providers are implementing this assessment in routine practice. Effective assessments are even less
common in older adults with English language barriers. Understanding organizational and provider-level
perspectives on assessment and documentation practices using electronic health records (EHRs), and
qualitatively interviewing and observing oncologists, will help inform future clinic workflow redesign. The
proposed career development and training plan supports Dr. Schiaffino’s trajectory toward becoming an
independent, aging-systems scientist through the following three goals: 1) Obtain advanced natural
language processing (NLP) algorithm development training to extract unstructured text from EHRs, 2)
Engage in observation and training in geriatric oncology care delivery, to understand clinical workflow
and clinical practices around assessment of age-related risk, and 3) Gain experience in clinical workflow
implementation science proposal development. This project will take place at SDSU, UCSD, and City of
Hope (Duarte, CA) with mentors who are experts in Geriatrics/Gerontology (Primary: Alison Moore, MD, MS);
Radiation Oncology/HSR (Co- Primary: James Murphy, MD, MS, UCSD); Geriatric Oncology/ Decision-Making
(Mentor: William Dale, MD, PhD, City of Hope); NLP/Bioinformatics (Mentor: Mike Hogarth, MD, UCSD);
Predictive Models/Biostatistics (Collaborator: Barbara Bailey, PhD, SDSU) and clinical implementation science
and Limited English Proficiency (LEP) disparities (Collaborator: Alicia Fernandez, MD, UCSF).

Public health relevance
PROJECT NARRATIVE Americans over age 65 are the largest group of patients and survivors of cancer in the U.S. and are also the most likely to experience sub-optimal treatment outcomes. Assessment of these factors, as part of a clinical exam, can help reduce risk. However, assessment and documentation of age-related risk is not well- coordinated, putting older adults at greater risk, especially diverse older patients such as those with limited English proficiency. The proposed project seeks to examine medical record and multi-level factors that can improve assessment of age-related risk and documentation with a broader goal of improving treatment planning and care for diverse older adults with cancer.